INSPIRE: Innovations in Suicide Prevention Research

ABSTRACT
Despite intensive prevention efforts from federal and state agencies, suicide remains a leading cause of
mortality in the United States (US), increasing by 36% between 2000-2022. In 2023 alone, 49,303 Americans
lost their lives to suicide. The impact of suicide is particularly high among vulnerable populations such as
adolescents and formerly incarcerated individuals.
Although much research has focused on causes and predictors of death from suicide, progress in suicide
prevention has been hampered by data linkage and methodological challenges. While national mortality rates
are known, entities with the potential to implement large suicide prevention initiatives – insurers, health
systems, and departments of corrections – lack the linked data to monitor suicide mortality in their populations,
establish benchmarks, and create an evaluation framework for prevention efforts. Many individuals who die
from suicide have had recent contact with a health insurance, health care, or correctional system, representing
critical missed opportunities to implement suicide prevention measures.
Funded from 2020-2025, our original “INSPIRE” grant (R01MH124752) established a living suicide
mortality surveillance system in North Carolina (NC) by securing all necessary data approvals and completing
individual-level linkages between state death records and large datasets on four key populations covering
10-22 years depending on the data source: the publicly insured (NC Medicaid), privately insured (large single
private insurer), a large integrated health system (UNC Health), and releasees from the Department of Adult
Corrections. We have updated these linkages annually and have used this surveillance system to define
benchmarks of suicide mortality in each population; evaluate policy impacts; identify risk factors for suicide
mortality, attempts, self-harm, and suicidal ideation; and predict short and long term risk of suicide outcomes .
Having invested the expertise, resources, and time to establish the INSPIRE living surveillance system and
demonstrate its potential, RFA-MH-25-135 now provides an opportunity to untap the full potential of this
surveillance infrastructure and further advance suicide prevention efforts. Over the next five years, we will
enhance the surveillance system by continuing annual updates, including additional important populations
(older adults), and performing enhanced cross-population linkages. We will utilize the established system to
evaluate the impact of several recent suicide prevention efforts in NC and build risk assessment tools tailored
to specific sub-populations and suicide mortality subtypes. Finally, we will move this research beyond Big Data
as we engage end users (clinicians and health administrators) to plan implementation of the risk assessment
tools into health care settings where they can be best utilized to connect people in mental health crisis with the
help they need to prevent suicide-related outcomes.

Public health relevance
PROJECT NARRATIVE We will enhance our existing INSPIRE suicide surveillance system through addition of Medicare enrolled population and cross-population linkages. We will utilize the enhanced INSPIRE surveillance system to evaluate the impact of recent suicide prevention efforts in NC and build tailored risk assessment tools. Finally, we will engage end users (clinicians and health administrators) to plan implementation of the risk assessment tools and develop integrated decision support tools for healthcare systems.